Dose flexible ultra-long-acting prodrug formulations for pediatric populations

Abstract
While antiretroviral therapy (ART) has significantly reduced AIDS-related mortality, significant treatment gaps
remain among children living with HIV-1 infection. The potential impact of emerging potent pediatric
formulations on viral suppression rates has been limited by factors common to daily oral ART. Additionally, the
pharmacokinetic (PK) profiles of orally administered drugs in children is dynamic making drug delivery by this
route unpredictable. Therefore, long-acting (LA) non-oral drug delivery approaches that could potentially
overcome these challenges are of significance. We have created a 6-month aqueous injectable formulation of
a bictegravir (BIC) prodrug with a shorter PK tail. The nanoformulated esterified medicine referred to as NDBIC
sustains plasma BIC concentrations of > 4X the 95% inhibitory concentration after a single injection. Based on
these encouraging results, we seek funds to launch an innovative approach that will produce a complete every
6-months integrase strand transfer inhibitor (INSTI) based regimen for treatment of HIV-1 infected pediatric
patients. Our innovative approach is focused on transforming well established daily oral pediatric therapies;
BIC with dolutegravir as the alternative INSTI, emtricitabine (FTC) and tenofovir (TFV) prodrugs, into ultra-
long-acting (ULA) dose flexible prodrug formulations. Pediatric friendly formulation excipients, prodrug linkages
and aqueous buffers will be used to further de-risk the process. We will leverage on the expertise of our
multidisciplinary team with a strong history of collaboration, pharmaceutical industry support, animal models of
pediatric drug development and PK/PD modeling to identify a safe and efficacious complete prescription ULA-
ART formulation. Our approach is supported by extensive and rigorous preliminary data. Drug choices,
prodrug, and formulation development, in vitro and in vivo screening and mechanisms, toxicology, PK, and
pharmacodynamic (PD) profiles in relevant animal models of pediatric drug development (Sprague Dawley
rats, humanized mice and non-human primates) will follow thoughtfully well-designed milestone-driven Go-No
Go criteria that seek to address the unmet needs of the pediatric patient, simplify manufacturing, scale up and
storage, evaluate potential adverse reactions of non-oral ART, and clinical pharmacology. We posit that
sustaining therapeutic drug levels in viral target cells (monocyte-macrophages and CD4+ T cells) and tissues
will improve treatment outcomes. A twice/year complete pediatric ART regimen will be identified for future
clinical development following the guidance and recommendations by the US FDA.

Public health relevance
Project Narrative We seek to develop a complete six-month antiretroviral therapy regimen for treatment of pediatric populations living with HIV-1 infection. Our approach could potentially improve adherence and treatment outcomes.